PROTEIN O-GLYCOSYLATION IN CRYPTOCOCCUS NEOFORMANS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. Technology developed in support of the aims of the NCRR Biomedical Glycomics grant is applicable to many different systems. The non-biased methods for glycan characterization are sufficiently sensitive to allow detection of minor glycans. The Doering lab has previously generated Cryptococcus mutants that present altered capsule morphology as a result of altered glycan synthesis. The glycan products of these mutant genes are not always known. We have used our glycomic technology to identify a novel phosphodiester linkage between Xyl and Man as a product of a specific xylosylphosphotransferase.